NHLBI WORKSHOP/CONFERENCE SUPPORT

The objective of this contract is for the Washington Business Dynamic (WBD) to provide the NHLBI with expertise related to planning and executing scientific workshops and other events to assist the Institute in conducting and implementing its biomedical programs. Meetings are held virtually, hybrid and in person. Scientific meeting services include planning and logistical support required by the Institute's advisory groups, task forces, and working groups. Support includes meetings covered under the Federal Advisory Committee Act (FACA) and those that are not covered by FACA. Among the stakeholders are the scientific community, the NIH scientific staff, other government leaders, and the general public.